Dietary impacts on organismal health through altering epigenetic silencing of transposable elements

PROJECT SUMMARY
Transposable elements (TEs) are widespread genomic parasites that occupy nearly half of the human
genome. The selfish replication and movement of TEs are generally harmful to organisms, and eukaryotic
hosts primarily defend against these adverse effects by depositing repressive epigenetic marks at TEs to
silence them. Our recent investigations suggest an evolved balance of this process—the epigenetic silencing
of TEs needs to be strong enough to reduce TEs’ harmful replicative movement, yet weak enough to avoid
inadvertent spreading of repressive marks to TE-adjacent functional sequences. Interestingly, growing
evidence shows that epigenetic modifications can be altered by diet, because dietary metabolites and nutrients
can act as substrates, cofactors, or inhibitors for enzymes responsible for such epigenetic modifications.
However, a critical knowledge gap remains regarding how diet-mediated changes in epigenetic modifications
may influence the epigenetic silencing of TEs and, thus, organismal health. We hypothesize that dietary
changes can negatively impact organismal health by perturbing the evolved balance of TE epigenetic silencing
through both weakened and enhanced TE silencing. We will leverage TE natural variation and combine that
with functional genomics and experimental genetics to address our evolution-driven hypothesis. Drosophila will
be used as a model system for its ease of handling for large screens, its shared mechanisms of epigenetic
regulation with mammals, and its unique TE features that offer an informative model for human TEs. We will
conduct large screens to identify dietary factors that alter the balance of TE epigenetic silencing and the
involved epigenetic modifying enzymes. This effort will use our newly developed fluorescence reporter system
that enables efficient quantification of the strength of TE silencing (Aim 1). We will perform epigenomic and
transcriptomic analyses of wildtype strains fed control and altered diets to characterize varying dietary
responses of TEs across the genome. This genome-wide profiling will use natural polymorphism of TEs and
compare the epigenetic states of homologous sequences with and without a TE insertion, pinpointing diet-
mediated changes at individual TEs. Using these functional genomic data under altered diets, we will also
investigate the predicted functional outcomes of perturbed TE silencing—elevated TE activity due to weakened
silencing or excessive spreading of repressive marks to TE-adjacent genes due to enhanced silencing (Aim 2).
Finally, by using pharmaceutical intervention to revert the functional outcomes of perturbed TE silencing, we
will directly quantify dietary fitness impacts that are mediated by altered TE silencing (Aim 3). By exploring
dietary factors that influence how organisms defend against TEs, and the subsequent impacts on genome
function and organismal fitness, this project will reveal previously unknown mechanisms by which diet acts
through epigenetic modifications to influence individual health. Our findings will provide a novel perspective for
gauging the full impacts of the ongoing and rapid shifts in human diets on our health.

Public health relevance
PROJECT NARRATIVE Transposable elements are selfish genetic elements that occupy nearly half of the human genome and have been associated with inherited diseases, cancer, and aging-associated diseases. This proposal will identify dietary factors that influence organisms’ defense mechanisms against transposable elements and investigate the consequential functional and health outcomes. Findings from this proposal will provide a novel perspective for gauging the full impact of how nutrition impacts health, which is critical to guiding dietary choices and interventions that support human health and prevent disease.